Title: Developing a novel drug for neurobehavioral deficits in FASD

Summary
Fetal Alcohol Spectrum Disorders (FASD) represent a range of lifelong cognitive, behavioral, and physical
impairments caused by prenatal alcohol exposure (PAE). The estimated prevalence of FASD is 2.0-5.0% in the
U.S. and Western Europe, causing substantial treatment costs. Currently available medications for FASD are
essentially limited to the management of ADHD and anxiety, and there is a strong need for new medications to
target other broader issues in FASD patients. Cogthera LLC aims to develop a drug to address cognitive and
learning difficulties in FASD by targeting a novel mechanism mediated by the KCNN2 channel that we discovered
to be affected by PAE. The patent for the use of peptide compounds targeting this mechanism is held by
Children's National Hospital (CNH). These compounds have shown improvements of behavioral issues in a
mouse model of FASD via intranasal application.
Building upon the successful selection of the top candidate peptide FA-1 through initial efficacy and safety
testing in the STTR Phase I study, this Phase II study focuses on the following objectives: Produce GLP-grade
FA-1 and comprehensively characterize its drug-like properties, bioactivity, pharmacokinetics (PK),
pharmacodynamics (PD), and safety in vitro (Aim 1); Optimize FA-1's formulation for intranasal administration,
evaluate its efficacy in FASD animal models of acute and chronic maternal alcohol drinking, and obtain regulatory
feedback through an INTERACT meeting with FDA to guide subsequent in vivo studies (Aim 2); Conduct single-
dose and multiple-dose PK studies as well as toxicity and safety assessments of FA-1 in both rodent (mouse)
and non-rodent (rabbit) models (Aim 3). These studies will generate critical preclinical data to establish safe and
effective dosing regimens, thereby supporting regulatory approval and facilitating IND submission.

Public health relevance
Project Narrative Our previous studies have discovered that suppressing abnormally upregulated function of KCNN2 channels is a promising new approach to improve neurobehavioral deficits associated with Fetal Alcohol Spectrum Disorders. Building on the success of the STTR Phase I study, the goal of this Phase II study is to obtain comprehensive data on the efficacy, pharmacokinetics, and safety of intranasal administration of our drug candidate peptide (KCNN2 blocker) to advance the project toward IND filing and clinical trials.